The Administrative Core

SUMMARY
The inception of the Columbia University Digestive and Disease Research Center (CU-DLDRC) in 2019 has its
foundational roots over the past 15 years through the resounding growth of basic, translational and clinical
research. The CU-DLDRC reflects the enthusiasm, collaborations, productivity and success of its members as
well as the long-term institutional support of digestive disease research at Columbia University. The CU-DLDRC
comprises an interactive group of 49 highly productive members (30 full and 19 associate), united by their strive
for excellence in adult and pediatric digestive disease research and care. Since the CU-DLDRC’s inception, the
Administrative Core (AC) has enhanced the collaborative research culture through the following endeavors: (i)
Fostering interdisciplinary networks and team science, and collaborations between basic and clinical
researchers; (ii) promoting education, training, mentorship and diversity, equity and inclusion (DEI); and (iii)
supporting new investigators. The CU-DLDRC’ central research theme “Epithelial Cells and their Interactions in
Digestive Homeostasis and Disease” encompasses two interrelated subthemes with major impact on digestive
health: “Epithelial Homeostasis, Metabolism and Regeneration” (Subtheme 1) and “Epithelial Interactions in
Inflammation and Preneoplasia” (Subtheme 2). Four Biomedical Cores provide access to cutting-edge
technologies and facilities: Clinical Research and Biospecimen; Organoid and Cell Culture; Bioimaging; and
Bioinformatics and Single Cell Analysis. The CU-DLDRC includes active Pilot and Feasibility (P/F) and
Enrichment (EP) Programs, empowering the next generation of scientists and promoting education and
intellectual exchange. The AC, as central component of the CU-DLDRC, will contribute to the collation and
implementation of its mission, activities and success via optimal organization of the research base; fiscal
management; coordination, evaluation and continuous evolution of its components; and communication with
oversight committees, the NIDDK and other DDRCCs. The AC is directed by experienced leaders with
complementary expertise: Robert Schwabe, MD, PhD (Director); Timothy Wang, MD and Kara Margolis, MD
(Associate Directors), supported by AC administrator Seetha Srinivasan, PhD. The AC will promote the mission
and success of the CU-DLDRC through these Specific Aims: To provide governance through efficient
administration, budgetary oversight, scientific leadership and interactions with oversight committees (Aim 1). To
ensure state-of-the-art services, efficient operation and cross-core collaboration by the Biomedical Cores (Aim
2). To promote the next generation of scientists and monitor their success via the P/F Program (Aim 3). To foster
a fertile environment and intellectual exchange through seminars and retreats, and to promote DEI via the EP
(Aim 4). To highlight the CU-DLDRC, its cores, educational activities and accomplishments on our website (Aim
5). Successful realization of these Aims will contribute to the effectiveness and success of the CU-DLDRC.